Pediatric Respiratory Illness Measurement System (PRIMES) Implementation in Community Hospital Settings

Acute respiratory illness is a major cause of hospitalizations in the pediatric population with over 75% of
admissions occurring in community–based (non-children's) hospitals. Focusing inpatient quality improvement
(QI) efforts on these conditions is likely to have a significant impact on outcomes. The Pediatric Respiratory
Illness Measurement System-Short Version (PRIMES-SV) tool is an abbreviated version of the previously
developed and validated PRIMES quality assessment tool. Using medical records data, PRIMES-SV
generates quality scores for both asthma and bronchiolitis, two of the most common conditions diagnosed in
children admitted to community hospitals. The overall goals of this study are to demonstrate the sensitivity of
PRIMES-SV measures to quality improvement (QI) interventions in community hospital settings, and to better
understand the contextual and provider-level factors associated with both the ability to improve performance
and to sustain those improvements.
The specific aims of the study are: Aim 1. To implement the PRIMES-SV tool in six geographically diverse
community hospitals to a) examine the degree of variation in performance across the hospitals and b) identify
implementation barriers to high performance using the Consolidated Framework for Implementation Research
(CFIR); Aim 2.To a) conduct a QI collaborative and improve overall performance on a sub-set of PRIMES-SV
measures among the six hospitals by targeting CFIR-linked barriers with aligned strategies, and b) assess
whether improved performance is associated with decreased LOS and costs; and Aim 3. To a) assess whether
observed performance improvements are sustained on the targeted PRIMES-SV measures and b) determine
which CFIR factors are linked with sustainment.
These aims will be accomplished by bringing together a diverse group of experts in the fields of QI
evaluation research, implementation science, and pediatric community-based hospital medicine. If using the
proposed approach to QI is successful and improvements are sustained, the PRIMES-SV quality assessment
tool used in combination with CFIR barrier-strategy matching could be widely disseminated to both community
and children's hospitals to facilitate quality improvement for these common and high cost pediatric conditions.

Public health relevance
Project Narrative In this study, quality improvement teams in six geographically dispersed community hospitals will work to improve on asthma and bronchiolitis quality measures included in the Pediatric Respiratory Illness Measurement System-Short Version (PRIMES-SV). If the PRIMES-SV quality measures are found to be responsive to implementation science-informed quality improvement strategies, this study has the potential to provide critical information needed to improve community hospital-based respiratory illness care and outcomes for children nationally.